A Multisystem Resilience Approach in the Assessment of Postsurgical Pain Trajectories

PROJECT SUMMARY/ABSTRACT
Osteoarthritis affects approximately 30 million people in the United States and is the leading cause of pain and
disability among older adults. Total joint arthroplasty (TJA) is among the most common elective surgery for
patients with refractory knee and hip arthritis. Although a proportion of patients achieve benefits from TJA, up to
34% of patients develop chronic postsurgical pain (CPSP) following the procedure, with approximately 33% of
patients experiencing high impact or bothersome pain. While risk factors underlying CPSP following TJA have
been well documented, the mechanisms of resilience that predict treatment success are poorly characterized
and not routinely assessed. Building on prior research, we propose a novel conceptual model of pain resilience
that defines resilient functioning as a dynamic and multidimensional process that engages numerous systems,
a concept referred to as multisystem pain resilience (MSPR). In our preliminary work, we have found that
individuals with a greater degree of protective resources across multiple domains (i.e., psychological, social,
health) exhibit more optimal psychological, physical, and pain-related functioning when compared to those with
a lower resilient phenotype. Thus, investigating a broad range of adaptive factors may provide important
predictive insights into the unique combination of resources that account for resilient response trajectories
following TJA. In line with the Precision Medicine Initiative, the aims of this prospective observational study are
to explore mechanisms associated with treatment response in patients undergoing knee and hip arthroplasty,
and to characterize associations between MSPR phenotypic profiles with pain impact and physical function
trajectories. To address this goal, 300 patients ages 18+ years undergoing knee and hip arthroplasty will undergo
prospective assessments of MSPR factors and outcomes at baseline and at five postsurgical time points over a
9-month period. Patients will complete measures across the following MSPR domains comprised of modifiable
factors associated with pain: 1) demographic, 2) health, 3) biological, 4) behavioral, 5) psychological, and 6)
sociological. Collectively, these aims have the potential to advance understanding of phenotypic mechanisms
underlying postsurgical pain impact and physical function trajectories and may be a step toward the development
of therapeutic modalities aimed at promoting enhanced recovery and reducing overall pain burden in patients
undergoing arthroplasty.

Public health relevance
PROJECT NARRATIVE Total joint arthroplasty is the most common orthopedic procedure for patients with refractory osteoarthritis, yet a significant number of patients fail to recover and develop chronic postsurgical pain (CPSP) following surgery. While risk factors for CPSP have been documented in this population, the mechanisms that promote resilience remain poorly characterized. Therefore, the goal of this project is to identify multisystem phenotypic profiles of resilience that predict postsurgical recovery trajectories in pain impact and physical function among adults undergoing knee and hip arthroplasty.